BONE MINERALIZATION AND CALCIUM HOMEOSTASIS IN WOMEN WITH AMENORRHEA

The purpose of this investigation is to measure the bone mineral content of the whole body, and specifically of the spine and hip, and total body calcium in young women with hypothalamic, hypoestrogenic amenorrhea and to quantify the effect of supplemental estrogen/progestin on bone mineral content and body calcium.